Comparative DNA sequence analysis of the yeast genome

We propose to determine the genome sequences of four Saccharomyces species (Aim 1), for the purpose of identifying conserved, and therefore likely functional features in their DNA sequences. Rather than focusing on proteins and protein-coding DNA (a common emphasis of such studies), we seek instead to find hidden functional features in non-coding sequence (Aim 2), such as sequences regulating gene expression, chromosome maintenance, and encoding non-protein coding RNAs. Because these kinds of sequences evolve rapidly, sequences of relatively closely related species need to be compared. We have come to the conclusion that alignment of S. cerevisiae DNA sequence to that of at least 3 other Saccharomyces species (i.e., 4-way alignments) will be necessary to observe conserved blocks of sequence that are significant. Whole genome shotgun sequencing (2-3-fold coverage) of the genomes of 4 different species, followed by limited filling of gaps in the 4-way alignments, seems like the most efficient and economical way to acquire the necessary data. We will assess our ability to recognize functional sequence elements based on their conservation by testing the function of some of the conserved sequences (Aim 3) with experiments designed to identify transcriptional regulatory sequences and the proteins that bind to them, as well as non-protein coding RNAs. Yeasts are excellent organisms for these studies because 1) their relatively small genomes makes the project cost effective, 2) a wealth of information on yeast is available for assessing the significance of conserved sequences, 3) incisive experiments can be designed to test the biological function of conserved sequences, and 4) the data will benefit the large community of scientists studying this important model organism. We hope to contribute to the development of comparative DNA sequence analysis as an approach to annotating genomes, and learn how to use it effectively.